Mechanisms of extrahepatic biliary proliferation and regeneration

PROJECT SUMMARY/ABSTRACT
Cholangiopathies are incurable, progressive extrahepatic bile duct (EHBD) disorders characterized by injury-
induced cholangiocyte hyperproliferation. Development of therapies for cholangiopathies requires better
understanding of cellular and molecular mechanisms regulating EHBD proliferation during homeostasis and in
response to injury. Molecular pathways that regulate cholangiocyte proliferation are currently not well
understood. This application aims to answer a fundamental question about mechanisms of EHBD regeneration
and explore strategies to modulate the proliferative potential of the biliary epithelium. The rationale for the
proposed research is that defining cellular and molecular interactions underlying cholangiocyte responses to
injury can offer novel therapeutic strategies for cholangiopathies and hepatobiliary regenerative medicine. Our
preliminary data suggest that Hedgehog (HH) and WNT signaling play important roles in EHBD homeostasis
and proliferation after injury. The overarching hypothesis for this proposal is that HH and WNT signaling
regulate crosstalk between epithelial and stromal cells to promote EHBD proliferation after injury. In
this proposal, we will use genetic mouse models and pharmacological treatments in vivo. Bile duct ligation will
be used as an injury model. Human and mouse EHBD organoid (BDO) co-culture with primary mesenchymal
cells will be used to directly study epithelial-stromal crosstalk and pathway interaction in vitro and enhance the
translational component of this project. Aim 1 will focus on HH signaling and determine if the Indian HH ligand
from cholangiocytes signals to GLI1+ HH-responsive fibroblasts to indirectly regulate cholangiocyte
proliferation. Aim 2 will focus on WNT signaling and test if WNT from GLI1-expresing cells is critical for
cholangiocyte proliferation. Aim 3 will focus on cell-cell and pathway interactions and determine if IHH from
cholangiocytes directly regulates WNT production by fibroblasts to induce cholangiocyte proliferation. Under
Aims 1 and 2 we will use transgenic reporter and loss-of-function mouse models, pharmacological inhibitors of
HH and WNT signaling, in situ hybridization, and immunohistochemistry techniques to define the in vivo
effects. Under Aim 3 we take a reductionist approach by using organoid co-culture models. It will also support
the development of robust new tools (transgenic mice and organoid models) and skills (in situ hybridization
and flow cytometry) to support an independent research program focused on fundamental signaling pathways
regulating EHBD. This new K08 application will also promote the development of the PI into an independent
NIH-funded investigator and support her long-term goal to understand fundamental mechanisms of EHBD
biology to ultimately improve outcomes in patients with cholangiopathies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because cholangiopathies, often affecting extrahepatic bile ducts, are poorly understood and, therefore, have no effective treatment options. This project will define cellular and molecular mechanisms underlying cholangiocyte responses to extrahepatic bile duct injury to serve as a basis for development of novel therapeutic strategies for cholangiopathies. Thus, the proposed research is relevant to the NIH mission that pertains to the improvement of health and quality of life.